Short Course on Experimental Models of Human Cancer

PROJECT SUMMARY/ABSTRACT
The goal of the annual Jackson Laboratory “Short Course on Experimental Models of Human Cancer” is to
train graduate students, postdocs and new investigators in the basic science and application of experimental
models of human cancer. The training program will immerse participants and faculty in a unique and highly
integrated scientific environment and empower the next generation of scientists tackling human cancer. The
integrated program will cover advances in three critical areas: experimental cancer models, modern technology
to assess mechanisms and outcomes and the interplay of the tumor microenvironment and the immune
system. It will teach classical approaches to mouse and human genetics, modern molecular genetic
methodologies, computational and bioinformatics concepts, ontological standards, and scientific and medical
ethics. Students will participate in lectures, workshops, poster sessions as well as will receive practical training
in bioinformatics, statistical genetics, mouse anatomy, genetic engineering with CRISPR/Cas9, necropsy and
the preparation of tissues for histopathological analysis. This course will take place at The Jackson Laboratory
(JAX), which hosts an NCI-designated Basic Cancer Research Center and is a global resource of mouse
models. The course will include sessions with patient advocates and community oncologists so that trainees
gain broad exposure and knowledge related to the clinical aspects of human cancer. The intensive, immersion
course is focused on graduate students, postdocs and new investigators. Nonetheless, JAX is eager to share
didactic lecture and seminar sessions with those individuals whose schedules, budget or clinical duties do not
allow them to participate in person. To share course content more widely, JAX will advertise and recruit
trainees and clinicians to participate in live virtual delivery of Experimental Models of Human Cancer. JAX is
deeply committed to training a diverse group of biomedical scientists; going forward and with support from NCI
and the Howard Hughes Medical Institute, we aim to train twice as many under-represented minority (URM)
participants in the Experimental Models of Human Cancer course than during the previous grant period.
!

Public health relevance
RELEVANCE TO PUBLIC HEALTH Cancer remains a largely incurable disease and the mouse remains a key model for human cancer. A cadre of highly skilled young investigators will be trained in cutting edge modeling of human cancer including experimental cancer models, modern technology to assess mechanisms and outcomes, as well as tumor microenvironment and the immune system.